Dynamic Variable Aqueous Humor Outflow and Glaucoma Therapies in the Human Eye

Glaucoma is a leading cause of blindness, worldwide. The only proven glaucoma treatment is intraocular
pressure (IOP) reduction. Elevated IOP is caused by increased aqueous humor outflow (AHO) resistance at the
trabecular meshwork (TM) of the trabecular AHO pathways. Medications can be used to lower AHO resistance
through these pathways, but patients can be medically non-responsive for unclear reasons. Trabecular ablation
was developed as a safe and logical treatment, but IOP-lowering efficacy is limited in large, well-controlled clinical
trials. Thus, current glaucoma therapies are not effective enough, and there are insufficient tools to fully assess
AHO anatomy and physiology across the entire eye to understand why. Aqueous angiography (AA) is an AHO
visualization method that has shown segmental AHO over the entire eye with high-flow (HF) and low-flow (LF)
regions. LF regions have been linked to glaucoma treatment success. However, while AA provides gold-standard
AHO information, it is an invasive method with risks. Thus, we must derive a biologically-focused anterior
segment AHO structure/function relationship and re-frame segmental AHO assessment as a non-invasive
structural test to fill this gap. To do this, specialized optical coherence tomography (OCT) approaches must be
taken to overcome the complex, large, and three-dimensional AHO pathway anatomy. Thus, our central
hypothesis is that improved understanding of the ocular structures that determine segmental AHO (particularly
LF regions) in normal and diseased eyes can improve current and lead to new glaucoma therapies. The
objectives are to understand the structural determinants and identify biomarkers of segmental AHO, use this
knowledge to test glaucoma treatments, and create new tools to better evaluate AHO pathways in humans. In
Aim 1, we will use AA, OCT, and lipid emulsion (LE) OCT-angiography (OCTA) in ex-vivo human eyes to define
the AHO pathway structures that define segmental AHO LF and HF subtypes. These areas will then be tested
using trabecular ablation to identify the best locations for improving outflow facility and reducing IOP. In Aim 2,
we will use OCT and OCTA in wild-type and glaucoma mice with high IOP to define AHO pathway structures
that define segmental AHO in a pathophysiological state. These areas will then be studied using glaucoma IOP-
lowering drugs. In Aim 3, we will develop a new robotic anterior segment OCT (AS-OCT) tailored to human AHO
anatomy with high spatial resolution, optimal spectral range to reach the desired depth, and robust safety
features. Robotic control improves speed, feasibility, and reliability. Early-stage clinical performance and
repeatability testing will be performed in healthy volunteers and glaucoma patients using body-position-induced
IOP alteration to iteratively optimize the operation protocol. This proposal brings together the optimal team. Dr.
Zhang is a bioengineer who has successfully designed many custom OCT systems, including for the anterior
segment, to improve ocular anatomical and physiological assessment. Dr. Huang is a clinician-scientist who
developed AA, has published on clinical AS-OCT, and cares for glaucoma patients.

Public health relevance
Glaucomatous optic neuropathy is a leading cause of blindness that is treated by eye pressure reduction, but eye pressure lowering treatments are not effective enough because current methods are inadequate for evaluating how glaucoma treatments interact with circumferential segmental aqueous humor outflow (AHO) anatomy and physiology around the entire eye. For example, current flow-based AHO assessment methods are invasive and carry risks, so a non-invasive approach that can evaluate the large and complex circumferential AHO pathway anatomy is better. Thus, this proposal will 1) use optical coherence tomography (OCT), OCT- angiography (OCTA), and aqueous angiography to define an AHO structure/function relationship in ex-vivo human eyes for testing using trabecular ablation, 2) use OCT and OCTA to define an AHO structure/function relationship in healthy and glaucomatous mouse eyes to understand AHO pathophysiology and for testing eye pressure lowering drugs, and then 3) develop, validate, and optimize a new robotic anterior-segment OCT tailored to human AHO anatomy with associated and rigorous safety, clinical, and repeatability testing in healthy and glaucomatous individuals.